Investigating the Role of Epstein-Barr Virus in Long COVID Pathogenesis

PROJECT SUMMARY/ABSTRACT
SARS-CoV-2 infection can result in the development of a constellation of persistent sequelae
following acute disease, which is known as Long COVID. Individuals diagnosed with Long COVID
frequently report unremitting fatigue, post-exertional malaise, and a variety of cognitive and
autonomic dysfunctions; however, the basic biological mechanisms responsible for these
debilitating symptoms are unclear. Previously, this research group profiled 177 individuals in an
exploratory, cross-sectional study encompassing multi-dimensional immune phenotyping in
conjunction with machine learning. Key immunological features distinguishing Long COVID were
identified and described in the Mount Sinai Yale –Long COVID (MY-LC) study. A striking finding
was an elevation in antibodies to lytic antigens of Epstein-Barr Virus (EBV) in Long COVID
participants, which may be indicative of more recent reactivation of EBV in these patients. In
addition, levels of these antibodies correlated with IL-4, IL-6 cytokine double-producing CD4+ T-
cells, which suggests that EBV reactivation is not merely incidental but reflects, mediates or
aggravates immune perturbations in these patients. The overarching goal of this proposal is to
provide a thorough insight into whether EBV reactivation contributes to LC disease pathogenesis
and symptomatology, building on current literature. The research plan proposed will utilize the
Iwasaki lab’s expertise in in vitro and in vivo modeling to assess whether SARS-CoV-2 infection
can reactivate EBV and contribute to lasting sequelae, as described in Aim 1. Aim 2 will leverage
large patient cohorts previously recruited through the MY-LC study and robust sample and data
availability to test whether patients with Long COVID characterized by recent EBV reactivation
experience unique immune alterations. Aim 2 will also test whether these responses correlate to
unique symptoms. The findings uncovered by these studies have the potential to deepen
understanding of one cause of Long COVID, and to inform future treatment of a growing, currently
largely-untreated patient population. Mentorship from an interdisciplinary group of collaborators,
who are experts in the proposed techniques, will facilitate this applicant’s training as an
independent immunologist.

Public health relevance
PROJECT NARRATIVE Individuals infected with SARS-CoV-2 often do not make a full recovery, but instead develop Long COVID. Patients with Long COVID frequently report lasting and debilitating symptoms that greatly impede daily function and quality of life. This project explores whether SARS-CoV-2 infection reactivates latent Epstein Barr Virus and whether recent Epstein Barr Virus reactivation in Long COVID patients is associated with unique symptoms and changes in immune responses.